Multi-Stable Compliant-Mechanism-Based Mattress for Bedsore Prevention

Abstract
Pressure injuries (i.e., bedsores) affect 2.5 million Americans every year and 60,000 die from them.
Although several commercial alternating-pressure and low air-loss mattress products already exist to
address this scourge, these products are not optimally effective and lack the evidence to deserve a strong
medical recommendation. Moreover, they are expensive, heavy, and loud, and can exhibit lack of air-
permeation, air leakage issues, and round-the-clock power consumption. We propose a multi-stable
compliant-mechanism-based (MSCMB) mattress to overcome these issues and optimally prevent
prolonged levels of harmful pressure in the existing immobile and aging population. During Phase I of our
current grant, which began May 1st, 2021, we successfully fabricated a bed that consists of 1,260 linear
actuator pistons that can be controlled by a computer to impart any undulating pressure pattern on a
patient’s back. By the end of Phase I (April 30th, 2022), we will have used this bed to complete a study,
which involves machine learning to determine (i) what factors predominantly affect bedsore prevention in
alternating pressure approaches, and (ii) what the optimal height of (i.e., amplitude) and distance between
(i.e., pitch) each pressure peak should be for different categories of patients. We will use this information
to inform the design of the final products that will be prototyped and perfected in Phase II. During Phase I,
we also generated a MATLAB tool that was used to design a large portion of our proposed MSCMB
mattress concept and have prototyped it to demonstrate its functionality and to collect preliminary data.
The design tool and the lessons learned during the fabrication and testing of the prototype will be heavily
leveraged in Phase II to successfully perform the proposed aims. These aims are to (i) create the final
MSCMB mattress products that best reduce pressure injuries for different categories of patients, (ii)
produce a smart phone app and a web-based computer software that can be used to remotely set the
switching frequency of the actuated versions of the MSCMB mattress designs, (iii) conduct a study to
identify the most effective kind and thickness of foam pad to use on top of each MSCMB mattress product,
(iv) determine and perfect the final process for manufacturing the MSCMB mattresses, and (v) perform a
user evaluation study of the MSCMB mattress products.

Public health relevance
Narrative The objective of this work is to learn what factors affect the prevention of pressure injuries (i.e., bedsores) via an alternating pressure approach and incorporate the knowledge learned within the production of a multi-stable compliant-mechanism-based (MSCMB) mattress, which will disruptively alleviate the suffering of the 2.5 million Americans, who are affected each year by such injuries. At the completion of Phase I (April 30th, 2022), we will have finished a study, which utilizes a custom-fabricated bed of 1,260 actuator pistons to impart any desired pressure pattern on a patient’s back, and will have used the bed in conjunction with machine learning to determine the optimal pressure pattern for reducing bedsores in different categories of patients. In Phase II, we will leverage the knowledge learned from this study and from designing and fabricating the preliminary MSCMB mattress prototype (also generated during Phase I), to (i) create final MSCMB mattress products that best reduce pressure injuries for different categories of patients, (ii) produce a smart phone app and a web-based computer software that can be used to remotely set the switching frequency of the actuated versions of the MSCMB mattress designs, (iii) conduct a study to identify the most effective kind and thickness of foam pad to use on top of each MSCMB mattress product, (iv) determine and perfect the final process for manufacturing the MSCMB mattresses, and (v) perform a user evaluation study of the MSCMB mattress products.